De Novo Mini-Metalloenyzmes with Hydrolase Activity

PROJECT SUMMARY
The major goal of the proposed work is to create, characterize, and optimize de novo binuclear mini-
metalloenzymes for hydrolase activity. Hydrolytic cleavage, or the breaking apart of a molecule by the
addition of water, is an essential biochemical reaction that governs cellular processes across all life
kingdoms. Several rare genetic diseases come from hydrolase malfunctions, making them important to
understand. Metal ions are frequently used to catalyze these reactions due to their ability to strongly
polarize the O–H bond in water even at neutral pH. A small artificial enzyme called DFsc, which
contains two metal ions in the active site, is capable of hydrolyzing small molecules and larger DNA
substrates. Activity was observed with zinc, which is commonly used by nature, and titanium, which has
no known natural function. This project seeks to (1) understand the structural and electronic factors that
contribute to hydrolase activity in the DFsc system and (2) develop additional mini-metalloenzymes with
metals underutilized by nature for environmentally-friendly and catalytically-efficient hydrolytic cleavage.
To accomplish these goals, we will design, produce, and comprehensively characterize a series of
DFsc proteins whose metal-coordinating amino acids are systematically varied. This library of proteins
will be screened for hydrolase activity using DNAse and phosphatase assays and a variety of metal
ions. Successful completion of these aims will result in a robust model system that will provide an
understanding of the structure-activity relationships in natural and artificial metallohydrolases.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Nature uses enzymes called metallohydrolases to break down biological molecules such as proteins and DNA, and their function is tied to a number of human diseases. In this project, we are designing, creating, and characterizing artificial miniature proteins with hydrolase activity using metal ions that are common (Zn) and underutilized (Ti, V) in nature. Insights gained from these studies will improve our understanding of how metallohydrolases work and build a foundation for using uncommon metals within protein scaffolds for hydrolytic reactions.